Small Circular mRNA Vaccines

Small circular mRNA vaccines
Abstract:
Vaccines save numerous lives each year. Conventional vaccines based on pathogens, DNA, proteins, or
peptides are associated with poor pharmacokinetics, limited biostability, preexisting anti-viral-vector immunity,
weak immunogenicity, or safety concerns over genomic integration or virulent reversion. The emerging mRNA
vaccines hold the potential to overcome the above issues with pharmacokinetics and safety using mRNA and
advanced drug delivery systems. However, despite efficient delivery, current mRNA vaccines rely on long mRNA
that is still associated with 1) limited biostability, though extensively modified, and the resulting limited shelf-life
even using cold chains and poor antigen translation efficiency, and 2) complicated enzymatic production. To
address these limitations, we propose developing antigen-encoding small circular mRNA (circRNA), which are
highly biostable and efficiently delivered by existing nanocarriers, as a novel platform of mRNA vaccines. Small
circRNA is comprised of minimal RNA elements to translate peptide antigens. Our preliminary data showed
several notable features of small circRNA vaccines: 1) in contrast to long mRNA, small circRNA leverages
automated RNA synthesizers for fast, efficient, and precise chemical synthesis and versatile functional
modifications; 2) even without any biostabilizing modifications, terminus-free circRNA prevents exonuclease
degradation and prolongs its in vivo half-life and shelf-life under freezing, fridge, and ambient temperatures; as
a result, circRNA showed efficient antigen translation and immunomodulation; 3) small circRNA vaccines
leverage current drug delivery systems for efficient delivery to desired tissues and cells, and the small circRNA
sizes can increase its loading capacity in nanocarriers, relative to bulky mRNA; 4) circRNA vaccine is self-
adjuvanted due to intrinsic immunostimulation; 5) in cells, circRNA produces long genuine peptide antigens that
elicit potent immunity; and 6) the modularity of circRNA vaccine allows its easy adaption for wide application. As
a result, low-dose circRNA nanoparticles elicited potent immune responses in both young adult mice and aged
mice, protected mice from target cell challenge, and mediated robust tumor immunotherapy. In this application,
Aim 1 will optimize the antigen translation and presentation of biostable small circRNA vaccines by circRNA
engineering; Aim 2 will study nanoparticle delivery of circRNA into immune tissues and cells, and the stability,
integrity, and antigen translation kinetics of circRNA vaccines upon delivery to target cells; Aim 3 will decipher
the immunomodulation mechanism by nanoparticle-delivered small circRNA vaccines; and Aim 4 will use human
papillomavirus (HPV)-associated cancer as a test bed to assess the prophylaxis and therapeutic efficacy of
nanoparticulate small circRNA vaccine in syngeneic and transgenic mouse tumor models. The PI (Early Stage
Investigator) has assembled a team with complementary expertise to conduct this study. If successful, this study
will lay the foundation to develop circRNA as a novel platform of mRNA vaccines for wide application in the
prophylaxis and treatment of diseases, such as cancer and infectious diseases.
Page 1

Public health relevance
Narrative: mRNA vaccine has great potential for the prophylaxis and treatment of many types of diseases, but current mRNA vaccine has complex and long structures associated with complicated enzymatic synthesis, limited stability, and suboptimal efficacy. Here, we propose to engineer small circular RNAs that are easily and quickly manufactured, efficiently delivered by existing drug delivery systems, highly stable in storage solutions and in live cells, and efficient at eliciting potent and long-lasting immune responses. If successful, this study would lay the foundation to establish small circular RNA as a novel platform of mRNA vaccines. Page 1